Molecular control of ischemia-induced tissue fibrosis

Abstract
Chronic ischemia induced tissue fibrosis contributes to numerous end-stage diseases. It is
well accepted that macrophages play a major role in the generation of fibrotic tissues whereby
dysregulated macrophage accumulation, activation, polarization and functions contribute to
uncontrolled production of matrix metalloproteinases and extracellular matrix remodeling. Under
pathological conditions, macrophages, along with fibroblasts and other cell types, serve as an
initial and/or additional source of TGF-β1 and significantly contribute to the fibrosis. Moreover,
endomyocardial biopsy specimens from patients with atherosclerotic coronary disease-induced
ischemic cardiomyopathy demonstrated 45% of replacement fibrosis. Thus, identifying the
signaling cascades in macrophage that regulates fibrosis in chronic ischemic diseases will have
significant clinical benefit. MKP-5 has been implicated in innate immune responses,
regenerative myogenesis and vascular inflammation. Our exciting preliminary data show that
MKP-5 is upregulated in the fibrogenic zone of the heart. Genetic deletion of MKP-5 protects
against early atherogenesis that leads to coronary artery insufficiency, decreases cardiac
fibrosis and ameliorates ischemia-induced cardiac dysfunction in vivo. In vitro mechanistic
studies and RNA-seq analysis suggested that loss of MKP-5 downregulated arrays of
profibrogenic pathway genes including TGF-β signaling in macrophages and circulating
monocytes. The central goal of this study is to identify the signaling cascades regulated
by MKP-5 in macrophage that lead to tissue fibrosis. By using a novel chronic ischemia-
induced cardiomyopathy model, we aim to: (1) interrogate the role of macrophage MKP-5 in
ischemia-induced tissue fibrosis, (2) uncover the molecular mechanisms of macrophage
MKP-5 in regulation of pro- and anti-fibrogenic signaling cascade, and (3) test the
therapeutic potential of a newly developed MKP-5 allosteric inhibitor against fibrosis in
vivo. We hypothesize that MKP-5 exacerbates tissue fibrosis through macrophage infiltration,
polarization and TGF-β signaling. The success of proposed study will define the role of MKP-5
in regulating chronic ischemia-induced tissue fibrosis; provide proof-of-concept for applying
MKP-5 inhibition for the management of this deadly disease.

Public health relevance
Project Narrative Insufficient blood supply of the heart vessels and consequential heart scar formation and failure is the most common cause of cardiac events, which lead to the most death in the world. Our research has discovered a new modulator (MKP-5) of controlling heart tissue scar formation. The main goal of this proposal is to test whether MKP-5 can be a drug target to prevent and/or treat heart tissue scar formation and dysfunction in pre-clinical models of heart disease. Research supported by this grant may help identify potential therapeutic strategies for regulating immune cell functions in the heart, which may reduce mobility and mortality of patients with cardiovascular diseases.